Doxy.me VR: A scalable virtual reality app to facilitate evidence-based immersive telemental health

PROJECT SUMMARY ABSTRACT
Telehealth-based mental health care (TMH) allows clients to access care more conveniently and privately while
achieving clinical outcomes equivalent to those of traditional in-person care. However, the format of
conventional TMH (e.g., text, audio, and webcams) inherently limits the ways therapists can engage clients in
specific evidence-based therapies, nonverbal communication, and the sense of being present with one
another. Collectively, these limitations may negatively impact therapeutic alliance, which is the single strongest
predictor of clinical outcomes. Incorporating virtual reality (VR) into mental health care has proven to be a
reliable way to enhance client engagement, immersive interactivity, and telepresence. To date, VR-based
mental health care remains highly localized to specific clinic sites or reliant on prohibitively complex and
expensive VR equipment. Doxy.me Inc., the University of South Florida, and Lucid Reality Labs collaborated in
a Phase I SBIR to research and develop Doxy.me VR–the world’s first effective, accessible, and scalable
platform for evidence-based immersive telehealth. The goal of this Phase II STTR proposal is to optimize the
scalability and commercialization of Doxy.me VR by enhancing its existing features, evaluating its clinical
efficacy, and prioritizing new therapy content modules. Industry standard, user-centered design practices will
guide Doxy.me VR refinements and enhancements necessary to optimize ease of use, presence, and clinical
utility in Aim 1. Aim 2 will consist of a fully-powered randomized controlled trial of 160 adults with specific
animal phobia comparing exposure therapy via Doxy.me VR vs. conventional TMH. To maximize the
commercial potential of Doxy.me VR, Aim 3 will include a mixed methods (quant→qual) survey of 200
practicing TMH providers and 20 follow-up interviews with those providers to identify and prioritize
development of new immersive telehealth solutions. This proposal addresses specific goals of the National
Institute of Mental Health, particularly NOSI NOT-MH-24-120, promoting access, quality, and effectiveness of
mental health care by making effective and engaging VR-based mental health care available at lower costs
from the comfort and convenience of home, with unprecedented accessibility.

Public health relevance
PROJECT NARRATIVE In the US, 1 in 5 adults are affected by mental health disorders and less than half of them receive effective care due to lack of access to therapists or the high stress associated with clinical therapy. Telehealth and Virtual Reality can make mental health care more accessible, acceptable, engaging, and effective, but only recently has the convenience of telehealth and immersiveness of Virtual Reality been combined to maximize their potential to meet mental health needs. This project will further optimize Doxy.me VR, an immersive, telehealth-based Virtual Reality clinic, by refining its existing features with direct end-user feedback, assessing its effectiveness when treating individuals with phobias, and identifying and prioritizing future modules and features to help it further meet the needs of therapists and clients.